TB Meningitis: Evaluating CSF Immunology to Discover Hidden Disease and Potential Immunomodulatory Therapies

Abstract
In Sub-Saharan Africa, tuberculous meningitis (TBM) is the second most common cause of adult
meningitis, and a major cause of morbidity and mortality among people living with HIV. While host immuno-
deficiency clearly drives TBM pathogenesis, pathologic immune responses can also worsen disease. The key
drivers of HIV-associated TBM pathogenesis remain undefined but likely differ from HIV-negative TBM, thus a
study of the pathogenesis of TBM in HIV-infected humans is warranted and innovative.
Opportunities for host-directed therapy in this vulnerable population remain unexplored. To optimize
treatment of HIV/TBM and improve survival, it is critical to fully characterize host responses at the site of
infection and identify immune signatures associated with good or poor outcomes. To this challenge, we bring
our skills in experimental immunology of tuberculosis, matched with an experienced research team with a
proven track record of clinical and translational research regarding AIDS-related meningitis in Uganda.
Diagnosing TBM is notoriously difficult. The poor sensitivity (~50%) of standard methodologies detects only
a subset of those with TBM, likely with the highest CSF bacillary burden. In these patients hypo-functional or
pathologic immune responses, representing opposite extremes of immune function, may contribute to poor
host control of infection. The higher sensitivity of Xpert Ultra enables semi-quantitative diagnosis of those with
a lower burden of CSF bacteria and identifies a group with better immune control of the infection. Our
preliminary data suggest that diagnosis with trace or very low Xpert Ultra is associated with better survival.
In this project, we propose a new microbiologic/immunologic framework for understanding TBM,
categorizing patients based on the differing Xpert Ultra PCR cycle-threshold, which serve as a surrogate for
CSF bacterial burden. We seek to interrogate this framework by defining disease outcomes including survival
and neurocognitive testing in these different framework groups, while correlating these findings with
immunologic analyses of cellular immune responses in the CSF.
Our central hypothesis is that CSF immune signatures correlate with key aspects of TBM disease
pathogenesis including sensitivity of diagnostics, disease outcomes, and treatment responses. To test this, we
will perform high parameter spectral flow cytometry and multiplex cytokine profiling of samples from the CSF
and autopsy specimens of patients with HIV/TBM. By comparing these comprehensive immunologic data in
groups of patients with either high or low CSF bacterial burden, in those with good or poor outcomes, and in
the context of a clinical trial of standard vs high dose rifampin treatment, we aim to define the key contributions
of host immunity to TBM pathogenesis. If our hypothesis is correct, the implications of this research are that
immunomodulatory therapy will need to be customized to address the paucity or excess of immune responses.

Public health relevance
Project Narrative This project seeks to characterize the immune system response in spinal fluid to TB meningitis. This work will improve our understanding of the causes of TB meningitis and how the human immune response contributes to the disease. The overall objective is to enable better medical care for persons with TB meningitis, by enabling better diagnosis and potential customized host direct immune therapies.